NARMS retail food surveillance in Ohio

Summary
Antimicrobial resistance is an increasingly critical threat to human and animal health. In the US
alone, >35,000 individuals die each year because of infections with antimicrobial resistant
organisms. A common source of resistant bacterial pathogen exposure is food, in particular fresh
retail meat products. Most foodborne bacterial pathogens present in retail meat products also
colonize the gastrointestinal tract of food animals during production. Contamination of meat
products occurs during the harvest process when GI contents, including fecal bacteria,
contaminate the carcass. Despite improved food safety, the burden of foodborne illness has
remained relatively unchanged for the past decade, affecting 1 in 6 individuals in the US annually.
To help address this important public health problem, we propose to continue as a NARMS retail
meat and seafood surveillance collaborating laboratory. As our contribution to the NARMS
program, we will accomplish the following specific aims: 1) Contribute to national surveillance of
foodborne pathogens and indicator bacteria as part of the NARMS retail meat and seafood
surveillance program, 2) Support outbreak investigations of foodborne disease by providing field
epidemiology and laboratory support to other agencies in Ohio, and 3) Conduct field research to
understand the reservoirs for zoonotic foodborne transmission, and the molecular epidemiology
of antimicrobial resistant pathogens and indicator bacteria in fresh retail meat products.
To accomplish these specific aims, we will serve as a NARMS retail meat and seafood surveillance
project contributing laboratory. As a large cluster surveillance site, we will sample retail poultry,
beef, pork, and seafood from retail stores within both metropolitan and rural Ohio. All required
monthly samples will be cultured for specific pathogens and indicator bacteria. The resulting
isolates will be further characterized and shipped monthly to FDA for antimicrobial susceptibility
testing, with duplicate isolates maintained in our culture collection. We expect to successfully
sample all required packages of retail beef, pork, poultry, and seafood annually that will help to
track the current state of antimicrobial resistance among foodborne pathogens and indicator
bacteria found in retail meat and seafood but will also impact future FDA policy and regulations
and monitor the success of actions and interventions. In addition to our contributions to the retail
food surveillance program, as a NARMS participating laboratory, we will be available to support
foodborne disease outbreak investigations in Ohio and nearby states as needed.

Public health relevance
Narrative We propose to continue as a NARMS retail meat and seafood surveillance collaborating laboratory. As a continuing participant, we will routinely recover, sequence, and report target pathogens and indicator bacteria, and submit appropriate isolates to the NARMS surveillance program. As part of the national NARMS network of laboratories, we will support other agencies in Ohio investigating foodborne disease outbreaks and contribute to improved public health through the prevention of foodborne disease and reduced zoonotic transmission of antimicrobial resistant bacteria.